Effects of Aging on Neuronal Lysosomal Damage Responses Driven by CMT2B-linked Rab7

Project Summary/Abstract The endosomal-lysosomal system is responsible for cellular protein degradation,
and thus for protein homeostasis (proteostasis) in all cells. Neurons are spatially complex, large cell types, and
must survive for the lifetime of an organism. This makes maintenance of the neuronal proteome unusually
challenging. Disruption of lysosomal protein degradation can lead to accumulation of toxic aggregates, neuronal
dysfunction, and death. Normal protein degradation can be disrupted via direct damage to lysosomes, which
leads to leakage of luminal lysosomal contents into the cytosol in a process known as lysosomal membrane
permeabilization (LMP), which can facilitate cell death. LMP is often causally linked to neurological pathologies
that disproportionately affect aging populations. Even though lysosomes are critical to neuronal proteostasis, the
response of neurons to LMP on a mechanistic level is poorly understood. Further, despite the intimate
relationship between endosomal and lysosomal function, the role of endosomes in LMP responses is unknown.
The small GTPase Rab7 is a master regulator of late endosomes and lysosomes. It is also critical for
autophagy. Mutations in Rab7 lead to Charcot Marie-Tooth 2B (CMT2B) disease, a progressive peripheral
neuropathy. My preliminary data suggest that Rab7 is an acute responder to LMP. Following LMP, Rab7
accumulates on various enlarged vesicular compartments, including late endosomes (LEs) and lysosomes (Lys),
in a hyperactive, GTP-bound state. Within neurons, this response is exclusively localized to the soma. In this
proposal, I aim to discover (1) the requirement of Rab7 activation for downstream LMP responses, such as
galectin-3 accumulation on Lys and enlargement of LEs, (2) the impact of CMT2B mutant alleles on known LMP
responses and Rab7 activation post LMP induction, and (3) the impact of age on Rab7 mediated neuronal
degradation and LMP responses. I posit that Rab7 activation is essential in coordinating early responses for
endosomal damage control in LMP.
I will test the hypothesis that Rab7 activation following LMP is an essential response that mediates a
protective pathway in neurons, which is disrupted in CMT2B mutant alleles. In Aim 1, I will explore the necessity
of Rab7 activation in (1) galectin-3 mediated lysophagy and (2) LE vacuolization in response to LMP. In Aim 2,
I will test whether Lys/LE responses and Rab7 activation in response to LMP are impacted in CMT2B. In Aim 3,
I will determine whether aging disrupts Rab7 mediated (1) cargo degradation and (2) LMP responses in wild-
type and mutant CMT2B neurons. Together, these experiments will determine homeostatic mechanisms in
neurons that address lysosomal insults and whether this is impacted in disease. My long-term goal is to discover
and characterize compensatory endosomal response mechanisms to lysosomal disruptions in LMP that will be
broadly applicable to neurological disorders for the ultimate design of better therapeutics.

Public health relevance
Project Narrative Maintenance of neuronal protein degradation through the endosomal-lysosomal pathway is essential for post-mitotic, aging neurons. Lysosomal membrane permeabilization (LMP) occurs commonly in aging related pathologies of the nervous system, but the cellular responses to disruption of the neuronal proteome during LMP are poorly understood. Identifying compensatory endosomal responses to LMP may allow us to develop novel therapeutic approaches for a vast number of neurological disorders that both affect the aging population and exhibit LMP pathology.